Leadership and Administrative Core (LAC)

PROJECT ABSTRACT SUMMARY - Leadership and Administrative Core (LAC)
The theme of the UCSF OAIC is "Predictors, Outcomes, and Amelioration of Late-life Disability: A Focus on
Vulnerable Populations." We are dedicated to better understanding and addressing late-life disability in
vulnerable populations - vulnerable due to either medical vulnerabilities (such as cancer with comorbid lung
disease and cognitive impairment) or to social vulnerabilities (such as isolation, poverty, and other forms of
social disadvantage). During our second cycle, the UCSF OAIC successfully expanded the work and impact of
our programs, creating a dynamic and collaborative center that has made key contributions to science and
investigator development in our thematic niche. In our third cycle, we will continue to build the people and
programs that are shifting paradigms in aging and improving clinical care.
The LAC is the glue that coordinates the OAIC Cores and maintains collaboration and will continue its focus on
tangible metrics of research productivity: publications in high impact journals and new NIH funding. To achieve
these goals, we have identified nine specific aims. They allow the Center to excel in its mission of developing
superb investigators and supporting the highest-quality science. Our aims also focus on building partnerships
with other programs at UCSF such as our CTSI, RCMAR, and ADRC and with the national OAIC network.
The LAC has the following Specific Aims:
1. To provide leadership, direction, and coordination across OAIC Cores
2. To provide day-to-day management of the UCSF OAIC, including administrative tasks such as the
annual progress report and communications with the OAIC Coordinating Center.
3. To manage fiscal matters, review use of Core resources, and make reallocation decisions.
4. To lead outreach efforts, linking the OAIC with other UCSF centers and the national OAIC network.
5. To assess opportunities for new uses of Core resources, with special consideration of opportunities for
translation between clinical research, practice, and policy.
6. To assess and plan areas of collaboration among UCSF OAIC Cores and with other OAICs.
7. To solicit, review, and fund proposals for REC, PESC, and DP awards in collaboration with relevant
Cores.
8. To organize activities of UCSF OAIC advisory boards and review panels.
9. To monitor Core progress and implement necessary remediation.
LAC Leaders Drs. Covinsky and Steinman will foster a mission-driven culture of excellence, achievement,
intellectual generosity, and collaboration, pushing the UCSF OAIC team to support research that translates into
better care for vulnerable older adults.